Administrative Core

PROJECT SUMMARY ADMINISTRATIVE CORE
The Center for Systems Neurogenetics of Addiction (CSNA) merges advanced experimental and computational approaches in sophisticated mouse model systems with experts in behavioral neuroscience, computational biology and genetics, to interrogate the overlapping biological factors underlying risk for psychostimulant addiction. The CSNA draws on the experience and expertise of three highly accomplished researchers based at The Jackson Laboratory (JAX); SUNY–Binghamton University; and the University of North Carolina Chapel Hill. By integrating these programs through resource sharing, experimental and analytical standardization, and collaboration, the CSNA will enable a synergistic, multi-dimensional analysis of risk for psychostimulant abuse, while sharing data, resources and expertise with the research community. To fully capitalize on the extensive knowledge base afforded by this geographically dispersed team, and to efficiently synthesize and disseminate novel methods, findings and educational opportunities, the CSNA will be guided by a strong, centralized and well-organized Administrative Core (Admin Core). The overall objectives of the Admin Core are: 1) Communication. The Admin Core will organize and oversee regular scientific meetings to foster communication and synergy within and across the projects and cores of the CSNA, and to nurture a strong, collaborative environment across all sites, including those external to JAX. Regular communication between Admin Core leadership, the Internal Executive Committee (IEC) composed of the PI and all Core and Project Leads, and an External Advisory Board (EAB) composed of experts in the field, will optimize both progress of the CSNA towards its goals and stewardship of the Center as a resource of national impact. 2) Oversight/Management. The Admin Core will provide scientific and administrative oversight of CSNA research projects and cores. This oversight will include assessment and decision-making, project management, timely preparation of reports, regular fiscal review, intellectual property management, regulatory compliance, involvement of institutional and programmatic resources, and regular review of research and publication progress. As part of its oversight and program review, the EAB will provide critical perspectives on CSNA progress, make recommendations on overall scientific direction, and provide guidance on logistic, scientific and fiscal challenges faced by the Center. The Admin Core, together with the IEC, are responsible for implementation of EAB recommendations. 3) Education, Outreach and Career Development. The Admin Core will provide outreach to further public awareness of addiction research and of the CSNA and enhance professional training, education and career development in the genetics of addiction. This will be accomplished through a suite of offerings that leverage the well-established resources available at JAX for education and outreach.